Interpreting Bone Morphogenetic Protein Gradients in Vertebrate Development

Project Summary/Abstract
Animal development consists of complex cell coordination and rearrangement via intercellular communications.
It is not well understood how progenitor cells interpret neighbor cell signals that impact cell fate decisions. One
critical signaling element in animal development is morphogen signaling. Bone morphogenetic protein (BMP)
acts as a morphogen to pattern the dorsoventral (DV) axis during vertebrate development, where BMP
concentration gradients correlate with different cell identities. To study the mechanism in which progenitors
interpret BMP gradients, I look to zebrafish development. Zebrafish are transparent during embryonic and
larval stages, facilitating high resolution microscopy of cell fate change and migration patterns. Zebrafish share
more than 70% of their genes with humans, making them excellent models for human development and
disease research. Using zebrafish embryos, I will manipulate BMP concentration, progenitor cell location, and
BMP signal duration within mesodermal progenitors and determine the morphogenetic outcome. In Aim 1 of
this project, I will investigate the mechanism in which BMP signal coordinates its migration and cell fate gene
expression that results in its characteristic morphogenetic output. With DV BMP morphogenetic signaling, cells
may be positioned in embryonic domains where the microenvironment affects a binary fate switch. To answer
my question, I will be using transgenic embryos to conditionally overexpress ectopic BMP signal. Transplanting
transgenic cells into wildtype (WT) embryos prior to gastrulation stages will allow for the analysis of transgenic
cell fate decisions within the WT environment. I will analyze time lapses of developing embryos containing
these transgenic cells using spinning disk confocal microscopy. Cell fates will be genetically assessed using in
situ hybridization and fate-specific fluorescent probes before, during and after gastrulation. In Aim 2, I will be
determining the role that BMP signal duration has on cell fate decisions. I will be utilizing the Auxin Inducible
Degron (AID) system to create specific durations of BMP signaling and BMP target gene expression in order to
determine how signal duration impacts fate. Because a direct BMP target protein inhibits the transcription of
cell fate specific transcription factors, I hypothesize that the duration of BMP signaling would change the
amount of time that this target gene is present, allowing cell fate genes to bind when they normally would not
be able to, thus altering cell fates. The combined use of cell autonomous reporter fish lines, transplantation,
gene expression analysis, transgenic fish utilizing the AID system, and spinning disk confocal microscopy will
allow me to test my hypotheses.

Public health relevance
Project Narrative The proper development of vertebrates requires the deployment of morphogen signaling gradients and the ability of cells exposed to the morphogen to interpret different levels of signal. This proposal will identify mechanisms by which cells interpret the Bone Morphogenetic Protein (BMP) morphogen gradient, which when disrupted can lead to disorders such as cardiac defects, undifferentiated mesoderm, lack of germ cells, eye abnormalities, gastrointestinal diseases, Sjögren’s syndrome, and various cancers. By understanding how cells interpret levels of BMP signaling, my research will shed light on the mechanisms of BMP-derived diseases and congenital syndromes and provide important insight into how cells interpret other types of morphogen gradients.